Identifying neural signatures of current and future suicidal thoughts and behaviors

Death by suicide has been steadily increasing in the last 20 years, and this risk is elevated among veterans,
particularly those with traumatic brain injury and psychiatric diagnoses. However, in the last 50 years,
improvements in identifying those at greatest risk for suicide, typically via self-report, have been limited.
Therefore, we propose that complementary and objective neurobiological markers of suicidal thoughts
and behaviors (STBs) can improve the identification of those at greatest risk. Preliminary brain markers
related to STBs have been identified in the cognitive control network (CCN), limbic network (LN), and the
default mode network (DMN). However, reliable and predictive brain markers of STBs remain elusive as there
are several methodological limitations in the previous literature. This study will address these limitations and
investigate neural markers of STBs using two different neuroimaging methods: resting-state fMRI and brain
activity during the suicide Implicit Association Task (s-IAT). Resting-state provides a stable and reliable
measure of intrinsic brain connectivity, whereas the behavior on the s-IAT (known as the d-score) measures
the strength of a participant’s implicit association between self and death. The d-score on the s-IAT is a better
predictor of future STBs than self-report, but little is known about neural activity related to the s-IAT.
DESIGN AND METHODS. This application utilizes a close collaboration with the Translational Research
Center for TBI and Stress Disorders (TRACTS), which has a comprehensive psychiatric and neuroimaging
database of over 800 post-9/11. This dataset provides the unique opportunity to compare STB groups with
control groups matched on psychiatric diagnoses, like depression and PTSD, that are differentiable only by the
absence of STBs (psychiatric controls; PCs). Using this existing dataset, resting-state fMRI will be used to
identify brain markers related to both a history of suicide attempt (SA) and current suicidal ideation (SI). Next,
we will determine if these brain markers predict future STBs using state-of-the-art machine learning
techniques. Lastly, an additional 100 veterans will complete the s-IAT with concurrent fMRI as part of their
participation in TRACTS. This will allow us to investigate the feasibility of detecting neural makers related to
implicit associations between self and death (d-score).
Aim 1: Identify neural signatures of previous suicide attempt and current suicidal ideation (n = 800, ~5% with
history of suicide attempt, ~10% with suicidal ideation). Hypothesis 1. We will identify neural markers in the LN,
CCN, and DMN, that differentiate those with STBs from PCs.
Aim 2: Determine if the STB neural markers identified in Aim 1 predict future STBs 1-2 years later at a follow-
up assessment (n=400; ~5% attempt suicide within the next 1-2 years and ~10% reporting current SI at follow-
up). Hypothesis 2: Models using the SA and SI neural markers identified in Aim 1 will predict which individuals
report STBs at a follow-up assessment with acceptable diagnostic accuracy (sensitivity and specificity).
Aim 3: Acquire preliminary fMRI data on the suicide Implicit Association Task (s-IAT) to determine the
feasibility of measuring brain activation related to self-death associations (d-score). Hypothesis 3: We will
discover preliminary neural markers of this STB-related cognitive process, which will partially overlap with
resting-state markers of STBs, and also include brain regions associated with self-referential processing.
Training Aims. This CDA will provide training in 1.) The assessment, prevention, and neurobiology of suicide,
2.) Advanced statistical and machine learning techniques, 3.) Task-based fMRI, and 4.) Preparation to submit
a competitive CDA-II.
IMPACT. This project will provide a foundation for a future CDA-II proposal investigating these neural markers
of STBs in high-risk populations and as targets for brain stimulation with the long-term goal of using these
neural markers to develop new treatments and improve suicide prevention.

Public health relevance
Current prevention methods for suicide primarily rely on self-report, limiting treatment to only those willing to express suicidal thoughts and behaviors. For this reason, identifying alternative brain-based measures of suicide risk could significantly improve suicide prevention efforts. This project will identify complementary and objective brain markers of suicidal thoughts and behavior with two neuroimaging approaches. Identifying these brain markers related to suicide will have wide-reaching implications for future diagnostics, identifying brain targets for interventions, and predicting future outcomes. The proposed study will serve as foundational work for new research to improve our veterans mental health and quality of life.